Core D. External Innovative Network Core

PROJECT SUMMARY/ABSTRACT – Core D: External Innovative Network Core
The objective of Core D is to facilitate the development and successful impact of research networks linking
researchers at UC Berkeley and beyond such that CEDA’s signature themes – both proposed and as they
emerge – can be supported and fostered. We build upon our currently existing high impact networks supported
by CEDA, particularly the National Transfer Accounts network that has great promise for continuing high profile
work with policy impact, as well as other productive CEDA networking activities. To achieve our objective, Core
D’s first aim is to support a variety of meeting and webinar activities aiming to develop new research ideas and
productive new collaborations advancing research on the economics and demography of aging. The second
aim is to conduct technical assistance to help produce high quality, harmonized data and analyses within
CEDA networks. Ultimately we expect to see more foundational research accomplished, allowing the
transformation of research into policy.